Investigating oncogenic mutations and regulatory mechanisms of HER2 by electron microscopy

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to address fundamental gaps in our understanding of HER2 receptor tyrosine
kinase (RTK) activation mechanism and regulation through direct structural and biophysical studies on nearly
full-length receptor. Aberrant HER2 signaling through amplification or oncogenic mutations is at the root of
many cancers and remains a key target of therapies. HER2, together with EGFR, HER3, and HER4 comprise
the Human Epidermal Growth Factor Receptor (HER) family of RTKs, indispensable for cellular homeostasis.
These receptors convert extracellular cues into intracellular responses through homo- and hetero-
oligomerization induced by growth factor binding. HER2 distinguishes itself as an orphan receptor with no
known ligand and signals by heterodimerization with other members of the HER family. We do not understand
how HER2 regulates its catalytic activity in the absence of ligand-bound co-receptors, but many HER2
oncogenic mutations compromise these mechanisms and confer activity in a co-receptor independent manner.
Several of those mutations fall outside of the kinase domain, but in the absence of structural understanding of
how growth factor binding on the extracellular side of the receptor increases the catalytic activity of the
receptor’s intracellular kinase domain, we cannot predict how these mutations elevate HER2 signaling, and
most importantly change HER2 vulnerability to known therapeutics. We hypothesize that the orphan receptor
HER2 features intrinsic structural mechanisms to regulate catalytic activity in the absence of ligand or co-
receptor and oncogenic mutations outside of the kinase domain overcome these regulatory mechanisms via
alterations in oligomerization or conformational states to produce aberrant activation.
Addressing our hypotheses relies on biophysical analyses of the receptor as a whole. In Aim 1 we seek
to determine a high-resolution structure of near-full length HER2 by cryo-electron microscopy (cryo-EM). The
lack of any high-resolution structure of a full-length RTK is attributed to challenges in expressing, purifying, and
stabilizing a homogeneous receptor sample. We have recently overcome these challenges for HER2 by
engineering a near-full length HER2 construct that is robustly expressed and purified in a stable form. Our
preliminary negative stain-electron microscopy imaging demonstrates high sample homogeneity that permits
structural investigations by cryo-EM. In Aim 2, we will leverage our abilities in isolating HER2 to biophysically
characterize the influence of HER2 oncogenic mutations on oligomerization state and structure by EM. We will
then correlate the in vitro observations with downstream signaling. The completion of this multidisciplinary
project will represent a significant scientific contribution, not only due to the technological advances required to
study single-pass transmembrane receptors but also in the light of learning how HER2 regulates itself without
ligand or co-receptor. Such knowledge could be applied to developing new drugs, selectively targeting mutant
forms of HER2, and counteracting drug resistance common with anti-HER2 therapies.

Public health relevance
PROJECT NARRATIVE The full-length structure of the receptor tyrosine kinase, HER2, has remained undetermined despite the role of HER2 as an oncogenic driver in human cancers and the critical importance of structural understanding for drug design. Historically, challenges in expressing, isolating, and stabilizing full- length receptor tyrosine kinases have prevented any high-resolution structural approaches. We have overcome these hurdles by engineering a near full-length HER2 construct capable of robust expression - a tool that permits, for the first time, its structure determination by electron microscopy (EM) as a wild type receptor or carrying prevalent oncogenic mutations.